OLN 455 CYCLOSPORINE EXPOSURE OF STABLE RENAL TRANSPLANT PATIENT WITH SANDIMMUNE

Determine the intra-patient varibility in cyclosporine pharmacokinetics of stable renal transplant patients treated with Sandimmune adn then converted to Neoral as primary immunosuppressive therapy and to exam the relationship of variability in cyclosporine pharmacokinetic on outcome. We continuing our efforts in recruitment and enrolling.